Understanding pain embodiment and opioid misuse risk in chronic pain using neuroimaging

PROJECT ABSTRACT
The opioid crisis remains an ongoing public health concern as annual deaths due to opioid overdose remain at
record-high levels. Chronic pain contributes to both non-fatal and fatal opioid overdoses, and the lack of effective
and safe non-opioid options for long-term pain management is a significant barrier to the treatment of substance
use disorders. There is an urgent need to better understand the factors linking co-occurring pain and substance
use to poor functional outcomes, such as overdose and pain-related suicidality. Both the sensory and affective
components of chronic pain are essential to consider as both contribute to the process of pain embodiment. Pain
embodiment is a part of the chronic pain experience that is characterized by a tendency to apprise bodily
sensations as a threat to bodily integrity. Chronic pain patients with high pain embodiment may experience more
pain-related anxiety and may be more motivated to use opioids as a safety-seeking behavior to escape pain-
related distress. Here, we propose to characterize pain embodiment and how it relates to risk for opioid misuse
and brain network changes as measured by resting-state functional magnetic resonance imaging (fMRI). We will
study healthy individuals, individuals with chronic pain, and individuals recovered from chronic pain with a state-
of-the-art imaging protocol and a comprehensive set of pain and clinical measures. Our central hypothesis is
that, in chronic pain, pain embodiment increases the risk for opioid misuse and that this relationship is reflected
in networks shared by addiction and central pain processing: the default mode network (DMN) and the salience
network (SN). Aim 1 will identify concepts of pain embodiment that relate to opioid misuse risk. Aim 2 will
determine how pain embodiment and opioid misuse risk are reflected in functional connectivity changes in the
DMN and SN. Aim 3 will determine how pain embodiment and opioid misuse risk influence concentrations of
proton brain metabolites in the anterior cingulate cortex, a major hub of the SN. Together, this proposal will
illuminate how pain embodiment is reflected by changes in central pain processing and offer novel insights into
the mechanisms contributing to poor functional outcomes in co-occurring chronic pain and opioid misuse.
An interdisciplinary team of mentors will provide training in clinical and psychological behavioral measures
regarding chronic pain as well as training in magnetic resonance imaging methods, including acquisition and
data analysis. This training will be complemented by clinical mentorship in psychology and physical medicine
and rehabilitation. This training plan was developed in collaboration with my Sponsor and Co-Sponsor to
complete the central goals of conducting independent, collaborative research; advancing communication and
grant-writing skills; effectively mentoring and teaching trainees in a supportive environment; and honing clinical
skills in preparation for the return to medical school. This training is ideal for a future physician-scientist with the
goal of improving patient care at the intersection of translational research and the clinical management of co-
occurring substance use disorders and chronic pain conditions.

Public health relevance
PROJECT NARRATIVE The overlapping public health crises of opioid overdose deaths and chronic pain has increased the co-occurrence of these conditions, and the isolation associated with both has resulted in increased rates of overdose and suicidality. Both chronic pain and addiction have been shown to alter central neuroprocessing and self-related narratives through a process called pain embodiment. The goal of this project is to characterize how pain embodiment in chronic pain contributes to opioid misuse risk and altered self-related neuroprocessing.